Socio-structural determinants of cannabis and derived psychoactive cannabis product use and consequences among young adults

PROJECT SUMMARY/ABSTRACT
Cannabis is the most commonly used federally illicit drug in the US, with rates increasing, particularly in young
adults. Since 2012, 22 states legalized cannabis for non-medical (i.e., recreational) use and have established
regulatory oversight for product safety. Meanwhile, derived psychoactive cannabis products (DPCPs; e.g., Delta-
8 THC) entered the US market as a result of the 2018 US Farm Bill, which classified cannabis products with
<0.3% Delta-9 tetrahydrocannabinol (THC) by dry weight as hemp, making DPCPs federally legal, but
unregulated. Although some states have prohibited or regulated DPCPs, others have not addressed DPCP
legality. As a result of this complex and/or ambiguous regulatory context, DPCPs introduce new public health
concerns (e.g., use in young people, contaminants, poisonings). This line of research aims to advance evidence-
based policy and practice to reduce cannabis and DPCP use, its consequences, and related inequities. Guided
by a multilevel Social Determinants of Health lens, we will examine legal, commercial, and individual
determinants of cannabis and DPCP use outcomes. While research on the impact of legalizing non-medical
cannabis on cannabis use has yielded mixed results, cannabis marketing/retail are well-documented
determinants of cannabis perceptions (e.g., risk, social norms), use motives, and use outcomes. Limited
research has focused on DPCPs given their recent emergence. There may be similarities in determinants of
DPCP vs. cannabis use (e.g., sociodemographic correlates). However, there may be key legal and commercial
determinants that differ; for example, DPCPs may be more popular in states without legal non-medical cannabis,
and DPCPs may use distinct marketing strategies. Given the complex federal vs. state policy/regulatory context
of cannabis and DPCPs, it is crucial to understand determinants and their impact on individual cannabis and
DPCP use outcomes in order to inform laws/regulations and interventions to address use and related inequities.
Our specific aims are to: 1) examine cannabis and DPCP marketing characteristics over time (2018-2024) with
regard to regulatory context and potential target consumers, using existing marketing surveillance data; 2)
examine associations between cannabis and DPCP state policy, marketing, individual determinants
(perceptions, use motives), use, and related consequences (e.g., driving after use), using longitudinal data of
4,000 young adults ages 18-34 in an ongoing R01; and 3) qualitatively assess young adults’ cannabis- and
DPCP-specific experiences with, and perceptions of, legal and commercial determinants of cannabis and DPCP
use (via semi-structured interviews). Building on Dr. LoParco’s existing knowledge and skills, the training goals
focus on: 1) legal and commercial determinants of health; 2) qualitative/mixed methods research and advanced
quantitative analysis; and 3) professional development. This study will yield novel, high-impact, policy-relevant
findings and uses rigorous methods to address NIDA research priorities and will facilitate the successful launch
of Dr. LoParco’s independent research career focused on cannabis policy, industry, and population impact.

Public health relevance
PROJECT NARRATIVE This 2-year F32 proposal will facilitate the successful launch of Dr. LoParco’s independent research career focused on multilevel determinants of substance use among young adults and related inequities. The proposed research uses a Social Determinants of Health lens and novel methods, and focuses on derived psychoactive cannabis products (DPCPs), which are an increasing but understudied public health concern; the specific aims are to examine: 1) cannabis and DPCP marketing characteristics in relation to state cannabis and DPCP related policies; 2) causal associations between cannabis/DPCP state policy, marketing, individual determinants (perceptions, use motives), use, and consequences (via longitudinal cohort data from an ongoing R01); and 3) young adults’ cannabis- and DPCP-specific experiences/perceptions regarding legal and commercial determinants of use (via interviews). Training goals focus on: 1) legal and commercial determinants of health; 2) qualitative/mixed methods research and advanced quantitative analysis; and 3) professional development.